2/2: Feasibility study to build a collaboration in genetics and genomic cancer research

Project Summary
This is a partnership between Hampton University (HU) and the Tisch Cancer Institute (TCI) at
Mount Sinai School of Medicine that seeks to establish robust collaborations on-site and online
training and education to increase HU faculty’s research capacity in the area of genetics and
genomics and health disparities, while increasing TCI research in health disparities, using the
examples of prostate and breast cancer. The final goal is to create a competitive and sustainable
joint Center for Genetics and Genomics Cancer Research, encompassing the genetics and
genomics aspects of health disparities to explain population differences in breast and prostate
cancer occurrence and outcome. The proposal is grounded in a longstanding and productive
undergraduate educational collaboration between faculty at these two institutions, but is distinct
in its focus, methods, and goals. Hence, the proposed program will utilize the best practices
learned from previous collaborative endeavors to inform and create an innovative platform which
will enhance research capacity at both institutions while addressing key institutional challenges.
Our goals will be accomplished through a series of well-coordinated training/educational activities
and two pilot research projects that were strategically chosen to meet our overarching goals of 1)
improving health outcomes in vulnerable populations, 2) addressing gaps in cancer disparities
research, 3) augmenting genomic, statistics, epidemiology expertise and 4) enhancing
investigator productivity and extramural funding competitiveness. Training and education will aim
to increase HU faculty’s research capacity in the area of genetics and genomics and health
disparities, using the examples of prostate and breast cancer. It will provide TCI ISMMS with
access and collaboration to scientific projects in breast and prostate cancer disparity etiology,
treatment and outcome, as well as to a mechanism to increase the diversity of the genetics and
genomics faculty, which has traditionally lacked diversity. To ensure the success of the training
and education program, we have assembled an excellent team of faculty with outstanding
mentoring and teaching track records, along with extensive expertise in developing and
implementing new initiatives aimed at diversifying the clinical investigator workforce and
eliminating health disparities. HU faculty will also be exposed to the most novel and cutting edge
methods in cancer genomics through the completion of the pilot research project.

Public health relevance
Project Narrative This is a partnership between Hampton University (HU) and the Tisch Cancer Institute (TCI) at Mount Sinai School of Medicine that seeks to establish robust collaborations through on-site and online training and education to increase HU research capacity in the area of genetics and genomics and health disparities, using the examples of prostate and breast cancer. The final goal is to create a competitive and sustainable joint Center for Genetics and Genomics Cancer Research, encompassing the genetics and genomics aspects of health disparities to explain population differences in breast and prostate cancer occurrence and outcome.